Targeting mechanisms of glycosaminoglycan accumulation and neurobehavioral dysfunction to improve outcomes from traumatic brain injury

Abstract
Traumatic brain injury (TBI) is a chronic health condition affecting over 70,000 individuals per year. Multiple lines
of evidence suggest TBI as a notable risk factor for the development of age-related disease through converging
biological mechanisms that are poorly understood. The pathophysiological mechanisms associated with the
onset and progression of age-related diseases are not completely understood. Therefore, a dire need for
innovative approaches to better understand the biological mechanisms induced by TBI is required for clinical
success to reduce the development of age-related disease. Ubiquitin C-terminal hydrolase L1 (UCHL1) is a
biomarker for TBI, and functions to maintain homeostasis of intracellular components. TBI upregulates brain
levels of prostaglandins (PG), which have been shown to interact with UCHL1 and cause neuronal dysfunction,
and possibly vascular dysfunction. We recently discovered a progressive accumulation of sulfated chondroitin-
sulfate glycosaminoglycans (CS-GAGs) in UCHL1 positive cells of mice exposed to TBI. Directed mutations to
the cysteine 152 residue of UCHL1 (C152A) can mitigate neurobehavioral dysfunction in mice exposed to TBI
by reducing PG-UCHL1 interactions. Our Preliminary Data show reduced CS-GAG accumulation in the brains
of C152A mice acutely following TBI compared to wildtype control mice. We hypothesize PG-UCHL1
interactions to mediate TBI-induced BBB disruption, CS-GAG sulfation/accumulation, and
neurobehavioral dysfunction. Humans with a history of TBI often present with vascular and neuronal
dysfunction, which are associated with age-related disease and have yet to be treated effectively. In this
proposal, we will investigate whether inhibition of PG-UCHL1 interactions with indomethacin (INDO) and a
UCHL1 mutant mouse (C152A) will attenuate TBI-induced vascular and neuronal dysfunction. Many studies,
including ours, have shown preclinical TBI models to induce BBB disruption, CS-GAG sulfation/accumulation,
and neurobehavioral dysfunction. We seek to elucidate a novel mechanism of TBI-induced vascular and
neuronal dysfunction. Understanding the mechanism(s) of CS-GAG sulfation/accumulation will lead to novel
therapeutic strategies to stop or reverse the course of age-related diseases associated with TBI. In addition,
determining whether PG-UCHL1 interactions can modulate BBB disruption, CS-GAG sulfation/accumulation and
neurobehavioral dysfunction would implicate new treatment strategies for predictable outcomes of TBI and age-
related disease. More specifically, we seek to determine 1) whether a selective inhibitor for PG synthesis is
sufficient to mitigate vascular and neuronal dysfunction, and 2) whether PG-UCHL1 interactions are required for
TBI-induced BBB disruption, CS-GAG sulfation/accumulation and neurobehavioral dysfunction. If fully
successful, results will suggest PG-UCHL1 interactions to play a major role in BBB disruption, CS-GAG
sulfation/accumulation and neurobehavioral dysfunction and provide a novel therapeutic strategy to prevent, or
slow the progression of age-related diseases associated with TBI.

Public health relevance
Project Narrative Clinical evidence suggests that vascular injuries, including those induced by traumatic brain injury (TBI) serve as a risk factor for the onset and progression of age-related disease. TBI upregulates brain levels of prostaglandins, which have been shown to interact with Ubiquitin C-terminal hydrolase L1 (UCHL1) and cause neuronal dysfunction, and possibly vascular dysfunction. In this proposal, we will investigate whether inhibition of PG-UCHL1 interactions with indomethacin and a UCHL1 mutant mouse will attenuate TBI-induced vascular and neuronal dysfunction.